Sterilization of the COSMIIC System

Abstract Summary
Sterilization testing of the COSMIIC System
The aim of this supplement is to conduct sterilization testing of the COSMIIC System
components, under currently accepted standards, and to make the testing procedures and
results available to the public under our open source licenses. The specific tasks to be completed
in this supplement are:
Task 1.0- Complete a Q-Sub with the FDA to gain insights into sterilization requirements for a
device covered in an early feasibility IDE
Task 2.0- Perform all required tests on the device based on FDA feedback
Task 2.1- Select a vendor and initiate the quoting process. Produce test materials for
sterilization.
Task 2.2- Finalize Packaging and land on challenge device
Task 2.3- Validate the cycle and kitting process
Task 2.4- Determine sample sizes for tests and shelf-life duration
Task 2.5- Run shelf life and shipping tests.
Task 3- Release results to the open-source platform

Public health relevance
Project Narrative Sterilization testing of the COSMIIC System The aim of this supplement is to conduct sterilization testing of the COSMIIC System components and to make the testing procedures and results available to the public under our open source licenses.